Comprehensive NeuroHIV Center

SUMMARY
Current treatment of HIV-1 infection has changed the face of the disease by converting a once acute deadly
disease to a chronic illness. As such, many other issues have surfaced that require close attention including
comorbidities associated with the presence of the viral genome, as well as the potential side effects of ART on
several tissues and cells including brain that impact on the homeostasis of neuronal cells thus contributing to
neurocognitive and behavioral disorders seen among people living with HIV (PWH). Other areas of concern
relate to social and structural determinants of NeuroHIV disparities in the PWH community. Now, it has become
increasingly clear that the landscape must move toward a cure by employing sophisticated, innovative, next
generation approaches and technologies that are aimed at the permanent elimination of HIV-1 in PWH and
protect uninfected individuals from HIV-1 infection at the cellular and molecular levels. Importantly, a parallel
approach to improve neurocognitive/psychological disorders in the HIV community as well as the use of
molecular strategies for elimination/protection must be implemented to end more than four decades of clinical
challenges caused by HIV-1 infection. By combining resources and expertise of our teams at Temple and Drexel,
we have developed a Comprehensive NeuroHIV Center (CNHC) facility to provide services to scientists from the
greater Philadelphia area and beyond to initiate and investigate the current issues associated with neuroscience
of HIV-1 from community to laboratory and clinic with an emphasis on neuropsychiatric/behavioral (a new area
of emphasis), continued studies on the neuroscience of HIV-1 infection, and the development of cure strategies
at the molecular and cellular levels by the elimination of HIV-1 proviral DNA from the host using a genetic
approach such as CRISPR gene editing-based technologies. We propose that this unique and unprecedented
strategy will have dual benefit in improving current challenges associated with HIV-1 infection in PWH community
and offer new opportunities for the development of a novel approach for mitigation/elimination of viral infection
by a highly collaborative and complementary group of scientists. Our goals remain to provide neuroHIV research
infrastructure and support utilizing and expanding the CNHC's rich clinical neuropsychological data from a
longitudinal cohort of PWH, including primarily Black/African-American and White participants that identify as
non-Hispanic or Hispanic origin well-characterized by deep sequencing and detailed immunophenotyping as
described in the Clinical and Translational Research Support Core (CTRSC), working closely with NeuroHIV
Community Partnership and Disparities Core (NHCPDC) and taking advantage of the expert services offered by
Viral Gene Editing and Bioinformatics Core (VGEBC), together with resources offered by the Cell Biology and
Functional Analysis Core (CBFAC), and the financial and intellectual opportunities offered by the Developmental
Research and Mentorship Core (DRMC). All of which are operationally optimized and orchestrated by the Central
Administrative and Management Core (CAMC) to maximize our achievements.

Public health relevance
NARRATIVE The overall goal of the Comprehensive NeuroHIV Center (CNHC) is to develop, improve and sustain an infrastructure to provide services to a large number of scientists from the Philadelphia and beyone are who are involved in high impact research towards neuroHIV. CNHC offers unique expertise and services in gene editing strategies and delivery, cellular neurobiology and functional assessments and neuropsychological, virological and immunological data within a well-characterized and longitudinal clinical cohort. CNHC will provide pilot funding for junior investigators to enhance training and research for the next generation HIV scientists.